Personal and social-built environmental factors of glucose variability among multi ethnic groups of adults with type 2 diabetes

Project Summary
Extreme ambient temperature (Ta), which is becoming more common due to climate change, has been
associated with the increased incidence of cardiometabolic disease and mortality. Dehydration induced by high
Ta stimulates gluconeogenesis in the liver and promotes insulin resistance. Increased blood flow to the skin
during heatwaves increases cardiac demand, resulting in cardiac ischemia, infarction, and stroke in individuals
with pre-existing cardiovascular disease (CVD). Thus, individuals with diabetes are particularly vulnerable to
heat waves due to impaired physiological responses to heat and CVD comorbidities. Glucose variability (GV),
measured by continuous glucose monitoring (CGM), is fluctuations in blood glucose levels over a given interval
of time (intra-day or inter-day) and is an important emerging parameter of dynamic glycemic control. Glycated
hemoglobin (HbA1c), a marker of the average blood glucose levels over the previous 2 to 3 months, is the
primary metric used to predict diabetic complications. However, in-depth analyses from large scale, randomized
trials, and epidemiological studies have indicated that HbA1c alone may not sufficiently predict the risk of
diabetes complications. To date, climate change and health (CCH) research has been done at the population-
level with aggregated data and HbA1c levels. Although the previous studies provided valuable insight into climate
change and diabetes care, the mean HbA1c level at the population level with aggregated data in different climate
zones makes it difficult to understand the real impact of Ta on individual patients. There is an urgent need to
address gaps in CCH research studying lifestyle behavioral responses to Ta under climate change, social-built
environment, and diabetes outcomes with high spatiotemporal granularity. We will collect time-stamped lifestyle
data using ecological momentary assessment (EMA) and actigraphy and perform 24-hour dietary recalls. CGM,
a real-time, unobtrusive glucose measure will be blinded from participants during the 14-day observation period.
We will collect hourly and daily Ta from weather stations, daily Ta estimates from the Daily Surface Weather Data
on a 1-km Grid for North America, and develop a high resolution (1 km2) spatiotemporally resolved hourly Ta
model in Connecticut using satellite data with a machine learning approach. Participants will also be asked to
wear a personal Ta sensor. Leveraging data in GV and multi-level personal (demographic, comorbidities),
lifestyle, and social-built environmental factors that our parent study provides, and linking them to Ta data, we
propose the following specific aims: (1) identify the risk groups who are vulnerable to high or low Ta by examining
demographics, comorbidities, lifestyle (physical activity, sleep, eating behaviors/diet), social-built environment
and GV among multi-ethnic adults with T2D for 14 days each in 2 seasons, (2) examine the influence of Ta on
time-varying lifestyle factors and GV, within-person across 14 days using the hourly Ta estimates at 1 km2 special
resolution to inform future personalized behavioral interventions, and (3) evaluate the feasibility and utility of the
wearable Ta sensor and compare the data with the model developed hourly Ta and observed hourly Ta data.

Public health relevance
Project Narrative Extreme ambient temperature due to climate change significantly impacts diabetes outcomes and is becoming a public health threat. The proposed study will identify vulnerable groups under a warming climate and guide the development of behavioral interventions and patient education on how to modify lifestyle behaviors to mitigate the impacts of climate change on diabetes outcomes. The study will provide valuable insight into developing strategies to promote health equity in vulnerable populations affected by climate change by improving relevant governmental, clinical, and infrastructural considerations in response to extreme ambient temperature.